Evolved RNA Recognition Motifs for Therapeutic and Gene EditingApplications

Summary/Abstract.
RNA-targeting approaches have received considerable attention, and remain major areas of
focus in both basic research and therapeutic development. We have reported TBP6.7, a laboratory
evolved U1A-derived RNA Recognition Motif (RRM), that binds HIV-1 trans-activation response (TAR)
hairpin (KD ~5 nM), has no endogenous human RNA hairpin targets, and inhibits TAR-dependent
transcription. More recently, we reported the 1.8Å crystal structure of the TBP6.7-TAR hairpin complex,
which led to structure-guided development of a cyclic peptide inhibitor of TAR-dependent transcription.
Researchers have used TBP6.7 as a central component in CRISPR-Cas-Inspired RNA Targeting
System (CIRTS), a programmable RNA modifying platform. CIRTS consists of an effector domain,
TAR-binding domain (TBP6.7), and a single-stranded RNA shield protein domain. When mixed with a
guide strand RNA (gRNA) consisting of a target sequence complementary region flanked by TAR RNA
hairpin, sequence-specific mRNA targeting (degradation or gene editing) is achieved. However, a
single TBP6.7:TAR binding pair, responsible for forming the necessary CIRTS fusion protein-gRNA
complex, dramatically limits number of mRNAs that can be targeted – to one per experiment. Using a
structure-guided approach, we will evolve new RRMs that bind TAR-derived RNA hairpins. Following
biophysical characterization of these complexes, they will be incorporated into the CIRTS platform and
mRNA degradation or gene editing will be measured using standard reporter systems (Dickinson lab).
In addition to TAR, we have evolved RRMs that bind the oncogenic precursor microRNA pre-miR-21.
Preliminary flow cytometry data indicates that a number of these proteins potently and selectively bind
pre-miR-21. We will use ELISA, SPR, and ITC to characterize these new protein-RNA interactions,
engineer and test mutant forms of these new RRM-RNA pairs to better understand the requirements
for binding, and measure RRM-dependent inhibition of DICER pre-miR-21 splicing. Collectively, this
research will lead to the development of new RNA-targeted therapeutic leads, expand our
understanding of sequence-selective RNA recognition, and develop new protein-RNA binding partners
for incorporation into the mRNA gene editing platform CIRTS – enabling multiplexed editing of specific
mRNAs in a single cell. Finally, funding for this research will expand research opportunities for
undergraduate and graduate researchers at Delaware State University – an Historically Black College
and University (HBCU). Given the makeup of our undergraduate and graduate student population, this
research will enrich the training of young researchers and scholars who are historically
underrepresented in Science, Technology, Engineering, and Mathematics (STEM).

Public health relevance
Narrative. One goal of this research is to evolve RNA Recognition Motifs (RRMs) that bind TAR-derived RNA hairpins, and the incorporation of these new RRM-RNA pairs into the CRISPR/Cas-Inspired RNA Targeting System (“CIRTS”) platform multiple. Orthogonal RRM-RNA pairs will enable multiplexed mRNA targeting. A second goal of this research is to evaluate the affinity and selectivity of RRMs we have evolved to bind pre-miR-21, an established RNA therapeutic target. We will work with two labs (Dickinson and Varani) to support our research efforts. Finally, this research will support the development of historically underrepresented scientists, in particular for graduate research in biological sciences and employment in the biopharmaceutical industry.